ADAPTIVE RESISTANCE TO NITRIC OXIDE

Nitric oxide (NO) is produced in mammalian cells by several NO synthases, including an inducible form with high output during inflammation. Since NO may contribute to carcinogenesis and age- related neurodegeneration, we wish to understand how mammalian cells counteract NO toxicity. We have identified a group of 12 proteins induced in normal human fibroblasts by exposure to subtoxic levels of NO, including the antioxidant enzyme heme oxygenase 1 (HO-1). We have shown that the induction of HO-1 mRNA occurs via NO-dependent changes in its stability. We will explore the mechanism of this regulation and try to define the signal transduction pathway for post-transcriptional control of HO-1. Other genes (e.g., MAP kinase phosphatase MKP-1/CL100) are controlled transcriptionally, and we will test specific transcription regulators for their roles in this expression. We have identified an adaptive resistance to NO in the rodent motor neurons: cells exposed to low-level NO that induces HO-1 become resistant to much higher (usually cytotoxic) levels of NO. We will characterize this response in various cell types by identifying NO-inducible genes and determining their roles in protection against NO-mediated toxicity. HO-1 knockout mice will allow us to define the defensive role of HO-1 in fibroblasts, neurons, and other tissues. This project involves parallel efforts to follow biochemical markers of nitric oxide damage (e.g., nitrotyrosine), to use genetics to establish the role of HO-1 in inducible resistance to NO, to elucidate regulatory and signal transduction pathways, and to identify and clone novel defense genes for NO resistance.